Endogenous metabolite restricts GM-CSF signaling pathway in pathogenic macrophages to ameliorate CNS Autoimmunity

ABSTRACT
Identifying a therapeutic option that can modulate the innate immune response without generally suppressing
the immune system as a whole has been a key barrier to improving treatment for patients with MS. Using
metabolic profiling, we have reported that resolvin D1 (RvD1), a pro-resolving lipid metabolite of omega-3
polyunsaturated fatty acids, is significantly decreased in the plasma of patients with MS. Consistent with this
finding, MS patients have lower levels of omega-3 metabolites, which are precursors of resolvins, compared to
healthy controls, a finding that has been replicated in animal models of the disease, experimental autoimmune
encephalomyelitis (EAE). Notably, we found that daily supplementation with RvD1 significantly attenuated clini-
cal symptoms in both chronic and relapsing-remitting EAE. These data are provocative for their translational
potential, particularly because the immune system is not depressed by RvD1 treatment as it is with steroids and
most other MS therapies. The immunomodulatory effect of RvD1 is mediated through its receptor, formyl peptide
receptor 2 (FPR2), leading to modulation of AMP-activated protein kinase (AMPK), an important regulator of cell
metabolism. In other human disease models, the RvD1-FPR2 signaling cascade protects by inducing an anti-
inflammatory phenotype in macrophages. However, the mechanism affording this protection remains elusive.
Granulocyte-macrophage colony-stimulating factor (GM-CSF) is a key player both in the pathology of both MS
and EAE, promotes an inflammatory environment and neuronal damage. There is a growing interest in inhibiting
the pro-inflammatory effects of GM-CSF signaling as a therapeutic target in MS. In our preliminary work, we
found that RvD1 treatment inhibited GM-CSF signaling in macrophages and that this inhibition was AMPK de-
pendent. However, how RvD1 affects AMPK activity and GM-CSF signaling to attenuate EAE is unclear. Our
long-term goal is to identify natural endogenous signaling mechanisms that can be harnessed to treat autoim-
mune diseases, particularly MS. Our overall objective here is to determine the mechanism of action of RvD1 in
resolving inflammation and disability in mouse models of MS. Our central hypothesis is that RvD1 attenuates
EAE disease progression by abrogating GM-CSF signaling resulting in the polarizing of pro-inflammatory mac-
rophages into an anti-inflammatory phenotype. And the underlying mechanisms of macrophage phenotype
switch are through FPR2-AMPK-dependent metabolic reprogramming. To test this hypothesis our specific aims
are: 1) to identify the effects of RvD1 on the cellular phenotype and function of CNS-infiltrating macro-
phages in EAE; and 2) to determine the effects of RvD1 on metabolic reprogramming in macrophages.
We will address these aims with a combination of immunological, biochemical and innovative metabolomic ap-
proaches that are already well in hand. The proposed studies will form the foundation for the development of
innovative therapeutic strategies to resolve inflammation during MS with no side effects and will likely apply to
other diseases involving pathogenic activation of the immune system.

Public health relevance
Narrative People with multiple sclerosis commonly suffer from relapses accompanied by damage-inducing inflammation, and current treatment methods suppress the whole immune system, resulting in unnecessary and ill-tolerated side effects. We have identified an endogenous metabolite that resolves inflammation without altering other components of the immune system. The proposed research will identify the mechanisms by which this endogenous metabolite resolves inflammation, ultimately leading to novel therapeutics for MS and potentially other autoimmune diseases.